Biostatistics and Data Management Core

PROJECT SUMMARY – Biostatistics and Data Management Core
The Biostatistics and Data Management (BDM) Core will support all Projects and the Comparative Effectiveness (CE) Core by providing centralized coordination of high-quality data collection, management, analysis, and sharing. The BDM Core includes six current (5 of which will collect new data) and two new Breast Cancer Surveillance Consortium (BCSC) breast imaging registries and a central Statistical Coordinating Center (SCC). The Core will increase efficiency by providing Projects with data collected from a common cohort of women and sharing novel statistical methods performed by a single analytical support team. The specific aims are to: (1) collect, pool, manage, and share high-quality data required to meet Project aims; (2) expand the BCSC data resource by linking BCSC data to woman- and facility-level measures of social determinants of health and artificial intelligence algorithm scores; and (3) collaborate with Program investigators to implement sound and efficient study designs and perform valid statistical analyses that address each Project aim. The BDM Core will accomplish these aims using existing and new data collected on 2.9 million women (including 81,000 breast cancer survivors with surveillance imaging) from 235 current and 44 new BCSC breast imaging facilities. The BCSC registries have built strong relationships with the participating breast imaging facilities and have established secure procedures for data collection and linkage. Data will be pooled and analyzed by the SCC, which has extensive experience in data management, analyzing complex longitudinal observational data, risk prediction modeling, and developing novel statistical methods as needed to overcome the limitations of existing methods. Following the BCSC’s well-established collaborative research policies and procedures, the BDM Core will continue its successes in sharing data with the broader research community. Using the unique set of resources available to the BCSC—our established and cohesive research network; integrated surveillance system of longitudinal, individual-level data on women, radiologists, and facilities; infrastructure for accessing well-characterized study populations; and expertise in statistical methods and outcomes measurement in community settings—the BCSC registries and SCC will continue working together to support this Program project in answering key questions that cannot be addressed otherwise. These combined strengths ideally position the Program’s research teams to determine the most effective breast cancer screening and surveillance strategies in community practice.

Public health relevance
PROJECT NARRATIVE – Biostatistics and Data Management Core The Biostatistics and Data Management Core will collect, manage, analyze, and share data and mammography images for all Projects. Data collected on 3.0 million women (including 83,000 breast cancer survivors) from eight breast imaging registries will be combined into common datasets that will be analyzed at a central Statistical Coordinating Center and made accessible to all Projects and Cores. BDM Core staff will work closely with Program investigators to ensure high-quality and efficient research practices.